Identifying Cell Type-Specific RNA Expression and Regulatory Changes in Entorhinal Cortex Clinical Samples of Alzheimer's Disease

Spatial and temporal regulation of RNA is key to cellular homeostasis and can become disrupted in disease. The
lifecycle of RNA can include splicing, modification, transport, and translation, which all require RNA-binding
proteins (RBPs), a class of proteins that bind and regulate RNAs. Specifically in the brain, there are many
neuronal and non-neuronal cell types that are each comprised of distinctive sets of transcripts with unique RNA
regulatory machineries. While there are genetic tools in mice to parse out cell type-specific RNA regulation, a
parallel tool does not currently exist to study this in human postmortem brain tissue, limiting the ability to study
human diseases.
We have developed crosslinking immunoprecipitation-Fluorescence Activated Nuclei Sorting (CLIP-FANS) which
will allow us to overcome this hurdle and for the first time, identify cell-type specific RBP mediated RNA regulation
in postmortem samples. CLIP-FANS builds on two previous methodologies: fluorescence-activated nuclei sorting
(FANS) to achieve cell type specificity, followed by high-throughput sequencing of RNA isolated by crosslinking
immunoprecipitation (HITS-CLIP) to analyze gene regulation in sorted populations. Here, we have built an
ordered approach and show preliminary data of the similarities and differences in the Hu-binding between
excitatory and inhibitory neurons in the human entorhinal cortex in the first iteration of CLIP-FANS.
One neurodegenerative disorder with dysregulation of RNAs and RBPs in Alzheimer’s disease (AD), a highly
prevalent disease and the leading cause of dementia. For therapeutic interventions, maximum benefit would be
achieved by targeting the first brain regions affected in AD, such as the entorhinal cortex, which has few studies
on gene expression changes and none on gene regulation changes. Therefore, a combined approach of RNA
sequencing of sorted cell types (FANSseq) and CLIP-FANS will generate cell-type specific gene expression and
regulatory data of the differences occurring in AD to identify potential targets for therapeutic intervention.

Public health relevance
CLIP-FANS provides for the first time, an approach that can identify cell-type specific RBP mediated RNA regulation in human clinical samples. Alzheimer’s disease is one neurodegenerative disease that has cell selective vulnerability and dysregulation of RBPs. CLIP-FANS and FANSseq will identify the cell-type specific gene expression and regulatory changes in AD to identify disease-specific differences for potential therapeutic targets.